Epitranscriptomics in human obesity and type 2 diabetes

PROJECT SUMMARY
Dysfunction of multiple metabolic cells contribute to the pathophysiology of the two major pathological states,
obesity and type 2 diabetes, which have a huge economic burden worldwide. Identifying the etiology of the two
linked pathological states continues to be an area of intense research with a focus on identifying new
regulatory pathways within tissues that impact metabolic function and cause dysfunction. There is a continuing
need to develop a systems biology framework that integrates real patient data to inform signaling within cells
and crosstalk between tissues to enable identification of potential new targets for effective therapy.
An emerging area of significance in human obesity and type 2 diabetes (T2D) is epigenetics that has primarily
focused on DNA methylation and protein modifications. A missing link in this epigenetic framework is the
modification(s) in mRNA and chromatin-associated regulatory RNAs (carRNAs) that have been shown to
contribute to gene expression regulation at both posttranscriptional and transcriptional levels. Current data
indicate altered expression of various regulators in metabolic tissues (e.g. human islets, adipose, liver, skeletal
muscle) in obesity and type 2 diabetes; however, the significance of these alterations and the impact on mRNA
and protein expression in real human tissues is virtually unknown. Consistent with the requirement of a RC2
mechanism, we will develop a comprehensive database of functionally important RNA modifications in selected
human tissues. We seek to interrogate alterations in the modifications of RNA, specifically, the two most
important modifications, N6-adenosine methylation (m6A) and pseudouridylation in key metabolic cell types that
are relevant for type 2 diabetes and obesity. In this proposal, we will: 1) Interrogate the mRNA and chromatin-
associated RNA modifications, m6A-sequencing and BID-ψ-sequencing at base resolution with stoichiometry
information in key metabolic tissues from patients with T2D and obesity; 2) Perform m6A and ψ QTL studies in
tissues from patients with T2D and obesity and validate the functional relevance of key mRNA and chromatin-
associated RNA modifications in in vitro studies; 3) Interrogate comprehensive transcription and enhancer
activity using ATAC-seq in the metabolic tissues from patients with T2D and obesity; 4) Perform eQTL studies
using transcriptional activity data obtained from KAS-seq and RNA modification results on carRNAs in T2D and
obese tissues, and perform validation in in vitro studies; and 5) Develop a large-scale resource database on
mRNA and chromatin-associated RNA modifications and transcription activity with correlation of common
genomic features for the larger scientific community. The success of this project will lay ground for the broader
community to take advantage of these data and our analyses for future basic and translational investigations
and therapeutic developments.

Public health relevance
PROJECT NARRATIVE The mechanisms and pathways that operate during the onset and progression of obesity and type 2 diabetes (T2D) are not fully understood. We will take advantage of emerging observations that modifications on ribonucleic acids (RNA) functionally impact metabolic tissues and recent development of enabling methods that sequence RNA modifications with base resolution precision. We seek to map and investigate functionally important RNA modifications in metabolic cells from humans with obesity and type 2 diabetes with the long- term goal of gaining new insights into the pathophysiology of this chronic disease.